Biostatistics and Clinical Research Core

BIOSTATISTICS AND CLINICAL RESEARCH CORE
PROJECT SUMMARY
The Biostatistics and Clinical Research Core assists with study design and logistics, as well as the collection,
analysis and integration of biological and epidemiological data using techniques of computer science and
statistics. Under the direction of Evan Dellon, MD, MPH, an experienced clinical, epidemiologic, and
translational researcher, the core provides assistance with database implementation and maintenance, web
applications, validated and secure data capture, quality control, data analysis, and statistical analysis. The core
offers full collaboration on sound statistical study design, study process engineering, data model development,
system design and implementation. This leads to secure and accurate data capture and management, linking
of various data types and sources, and data extraction and reporting for analytics. The Core provides an
interface between basic scientists and informatics specialists to support translational research. The Core
provides essential services to the large group of clinical epidemiologists who are members of our center. The
clinical research component of the core includes assistance with study start-up, IRB approval, IND, regulatory
issues, contracting, clinical coordinator staffing, data and specimen collection, specimen processing, quality
control and monitoring. The specific aims of the core are: 1) To provide consultation on biostatistics and study
design during the design, conduct and analysis phases of research. 2) To offer data collection and data
management services including forms development, enrolment tracking, data capture, data validation, data
security and confidentiality, database closure, statistical programming, application development. 3) To enable
members and trainees access to large claims databases such as IMS Pharmetrics, MarketScan and Medicare.
4) To support clinical research through consultation, regulatory support, contract negotiations, and data and
specimen collection provided by a team of experienced study coordinators. 5) To deliver training and education
about sample size and power calculations, study design and analysis.